The Historically Black Colleges/Universities and Communities Worker Health and Safety Training Program

Project Summary/Abstract
The Deep South Center for Environmental Justice, Inc. Hazardous Waste Worker Training Center provides
training to hazardous materials and wastes workers who may perform jobs covered by the Occupational
Safety and Health Administration's (OSHA) Hazardous Waste Operations and Emergency Response
(HAZWOPER) standards and assist employers in complying with OSHA standard 29 CFR 1910.120.
The Consortium's goal is unique as its emphasis is on underserved populations in its Hazardous Waste
Worker Training Program (HWWTP) and Environmental Careers Worker Training Program (ECWTP); and
populations critical to post-disaster recovery in its Hazmat Disaster Preparedness Training Program (HDPTP).
The parent grant HWWTP is designed to provide model occupational safety and health training for workers who are
or may be engaged in activities related to hazardous waste removal, containment or chemical response. The
emphasis is on servicing workers of entities where health and safety training are critical to the worker’s wellbeing.
These workers include emergency responders and small municipality city workers and or cities where budgeting
restraints or working conditions, greatly reduces or eliminates the possibility of training. Volunteer fire departments
and small county police forces, city health department employees, port authority workers, mosquito control
employees, HBCUs, small minority and disadvantaged businesses are workers the Consortium has trained.
The parent grant ECWTP component is designed to deliver comprehensive worker training to increase the number
of underrepresented and disadvantaged minority adults employed in the fields of environmental restoration,
hazardous materials and construction. The program goals are: (1) to serve underrepresented and disadvantaged
adults living near hazardous waste and or contaminated property at risk of exposure to ambient hazards; (2) to
provide additional pre-employment services inclusive of study skills, math, reading, life skills to increase program
retention and completion; and (3) to successfully place trainers in jobs in the environmental restoration and
construction fields.
The proposed project is designed to work within the HWWTP framework of the parent grant, providing additional
training courses as outlined in this application, reaching communities in Pensacola, FL, a current HWWTP/ECWTP
training site under the parent grant, providing health and safety training to address the needs of worker populations
including communities, volunteers, day laborers, and other vulnerable worker populations following Hurricanes Ian
and Nicole, two major declared disasters pursuant to the Robert T. Stafford Disaster Relief and Emergency
Assistance Act (42 U.S.C. 3 5121 et seq.), which affected target communities in 2022,

Public health relevance
Project Narrative The HBCU and Communities Consortium Hazardous Waste Worker Training Program is uniquely designed to reach populations for training that, due to poverty and or racism, have been disenfranchised and excluded from opportunities existing within a society that has a unique history especially in the South that is teeming with the vestiges of racial inequality and social injustice in ways that continue to manifest in social and environmental determinants of health and well-being. The training program is informed by research and history on the intersection of race and place and the program also addresses basic inequities in resources for different communities across the country (rural vs urban) as well as differences in priorities for municipalities and city agencies, with training being first to be cut. Additionally, the Consortium is unique in its make-up in that it includes Historically Black Colleges and Universities (HBCUs) and Community Based Organizations (CBOs), that by design, serve the selected target populations.